ADOPTING RETARDED CHILDREN: FAMILY STRESS AND COPING

The proposed research aims to continue studying the adjustment of families rearing children with developmental disabilities (DD) prospectively, thus contributing to the understanding of what parent and family characteristics at an earlier time lead to better or poorer adjustment at a later time. This comparison is done with a unique sample of families who have knowingly adopted children with DD, as well as with the more typical families who have birth children with DD. The continuing investigation has two primary and interrelated goals. First, it will extend the prospective measurement to a critical, but understudied period: Transition to adulthood. Because this period is likely to be one of increased demands and strains, it is especially important to ascertain those parental and child characteristics, as well as family context, that influence the degree to which specific family members adjust well or poorly. Hypotheses to be tested with regard to this time period relate to parental personality and religiousness, child maladaptive behavior and independence of functioning, and the role of adoptive or birth status in adjustment. The second goal involves the extension of family measurement from self- and other-reports to behavioral observations. The intent is to anchor the current findings with regard to neuroticism, or mental stability, to the way parents interact with each other and their children with DD. In sum, this research has important mental health consequences for identifying families at risk for later dysfunction, thus enabling the implementation of primary, secondary, and tertiary prevention efforts.